Operationalizing Machine Learning and Discrete Event Simulation Models to Improve Clinic Efficiency

PROJECT SUMMARY
Physicians often report feeling pressured to see more patients to maintain revenue, while having less available
time for patient care. Systematic data-driven methods for efficiently scheduling patients are important as
physicians are pressured to see more and more patients. We propose that real time prediction models of
patient visit lengths, the likelihood of missing appointments, and of patient wait times will help schedule
patients more efficiently. Clinics will be able to safely overbook to avoid empty slots from missed appointments,
have guidance for scheduling urgent add-on patients, and provide wait time estimates for patients when there
are delays. We will develop methodologies for accessing data needed for these predictions in real time and
propose that the integration of these models into workflows will improve scheduling accuracy, patient wait time,
and patient satisfaction, while also increasing clinic volumes.

Public health relevance
PROJECT NARRATIVE Physicians report feeling pressured to see more patients to maintain revenue, while having less available time for patient care. Machine learning and discrete event simulation model predictions can help schedule patients more efficiently, but need to be integrated into the EHR and scheduling workflows to be effective. This study will develop methodologies for accessing real time data in the electronic health record (EHR) for research applications and predictive models so they can be integrated into scheduling workflows, and then will evaluate their effectiveness for clinic efficiency and patient satisfaction.